Precision Prediction of Right Ventricular Size, Function, and Outcomes in Patients with Repaired Tetralogy of Fallot

PROJECT SUMMARY: Dr. Son Duong (PI) is a clinician-scientist specializing in pediatric cardiology and
advanced cardiovascular imaging at the Icahn School of Medicine at Mount Sinai (ISMMS). The primary
objective of this application is to support the PI’s career development into an independent investigator of the
translational application of artificial intelligence to cardiovascular imaging and patient risk prediction in patients
with tetralogy of Fallot and other congenital heart disease. Patients with repaired tetralogy of Fallot (rTOF) are
at risk of are at increased risk of heart failure, arrhythmia, and sudden cardiac death, but current methods of
clinical risk stratification for poor outcome are inaccurate and limited in the feature set they incorporate.
Accurate assessment and monitoring of right ventricular (RV) volumes and ejection fraction (EF) are critical for
effective management of patients with rTOF, and thus cardiac MRI (cMRI) is recommended every 1-3 years in
adulthood because traditional methods for quantitative RV assessment are limited. Frequent cMRI is a patient
and system burden which may limit care. This proposal will leverage deep learning tools for the following
specific aims: Develop and validate a prediction tool of RV volumes and EF from 12-lead electrocardiogram
waveforms and two-dimensional echocardiographic video (Aim 1); and incorporate electrocardiogram,
echocardiogram, and electronic health record data into a multimodal clinical risk stratification tool (Aim 2). The
PI’s training plan focuses on coursework, tutorials, and seminars/workshops in four key areas: (1) statistical
machine learning, (2) deep learning, (3) patient-oriented clinical risk prediction, and (4) career development. To
meet these research and career development goals, the PI has assembled an expert cross-disciplinary
mentorship team consisting of primary mentor Dr. Girish Nadkarni MD, MS (Professor of Medicine and Division
Chief of Data Driven and Digital Medicine), a clinical informaticist with expertise in machine- and deep learning;
co-mentors Dr. Bruce Gelb MD (Professor of Pediatrics and Genetics and Genomic Sciences and Dean of
Child Health Research), a pediatric cardiologist with extensive expertise in study design and scientific career
mentorship; Dr. Hayit Greenspan PhD (Professor of Diagnostic, Molecular and Interventional Radiology, and
Director of Artificial Intelligence in Imaging), a computer scientist with expertise in deep learning in medical
image analysis; and Dr. Brett Anderson (Associate Professor of Pediatrics), an expert of multicenter outcomes
research in pediatric cardiology. The ISMMS Department of Pediatrics has a strong track-record of NIH funding
and successful mentorship to scientific independence. They will provide the PI with access to cutting-edge
computational power, clinical data infrastructure, and robust collaborative and educational platforms, as well as
protected time to ensure the PI’s success. The results from these research aims will set the foundation for
future R01 studies for multicenter validation, expansion into other congenital heart disease populations, and
translation of these findings to clinical practice in a prospective fashion.

Public health relevance
Project Narrative Adolescent and adult patients with repaired Tetralogy of Fallot, who are at increased risk of heart failure and sudden cardiac death, require frequent cardiac MRI evaluation of right ventricular volumes (which are poorly assessed by traditional ECG and echocardiography). To improve risk stratification and reduce the need for cardiac MRI, which is resource-intensive and unavailable to some, we will create an algorithm to predict right ventricular size, function, and clinical outcome from ECG waveforms, echocardiographic video, and clinical data using deep learning technology. This mentored research proposal, along with comprehensive training in machine learning methods for clinical risk prediction and career development, will position Dr. Son Duong as a leader in the translational application of machine and deep learning technologies to congenital cardiology and cardiac imaging, and lay the foundation for successful transition to independent R01 funding.